Impact of Sleep Disordered Breathing on Overnight Cardiac Injury in Patients with Acutely Decompensated Heart Failure

Project Summary and Abstract: Sleep disordered breathing (SDB), including obstructive sleep apnea (OSA) and central sleep apnea with Hunter-Cheyne-Stokes respirations is common in patients with heart failure,1,2 is exaggerated during acute decompensation,3,4 and may potentiate acute cardiac injury in this high-risk setting.5 Mechanisms include large, negative pleural pressure swings (increased left ventricular afterload via increased transmural pressure),6,7 cyclic hypoventilation (hypoxemia, hypercapnia, acidosis),8 and arousal with catecholamine surges (arrhythmia).9,10 While in aggregate, the data regarding treatment of SDB with positive airway pressure have not shown improvement in clinical outcomes in patients with chronic stable heart failure,11-15 there is a growing body of literature suggesting that acutely decompensated heart failure (ADHF) may be the preferable time for intervention. Continuous positive airway pressure treatment has been shown to improve acutely left ventricular ejection fraction in heart failure patients with sleep apnea.16,17 Moreover, expedited SDB work-up and treatment during (or soon after) hospitalization for heart failure exacerbation reduces readmission rates. 18,19 Despite these observations, standard treatment of ADHF does not typically involve sleep assessment. Reasons are multiple but may include lack of clear demonstration of overnight cardiac injury, as opposed to transient dysfunction during SDB events. New generation troponin assays have now been developed which now allow a highly sensitive assessment of sub-clinical cardiac injury,20-22 and these assays have not yet been adequately studied in the context of SDB and acute heart failure. Based on these concepts the purpose of this project is to determine if sleep disordered breathing results in a measurable overnight increase in cardiac injury-specific serum biomarker expression in patients admitted to the hospital with ADHF. Type and burden of SDB events will be assessed using portable respiratory polygraphy (i.e. a home sleep apnea test), and blood samples will be collected pre and post-sleep. This protocol will be performed once upon admission, and again in a second phase prior to discharge to determine if a period of medical heart failure management attenuates cardiac troponin release associated with sleep apnea. Findings of this research may have important implications for how SDB affects the heart, and for a multidisciplinary approach to the treatment and prevention of acute heart failure. Results may also be important for the planning of future interventional studies. This fellowship project will take place at the Sulpizio Cardiovascular Center, which provides a full spectrum of cardiovascular care, at the University of California San Diego, a leader in the study of respiratory physiology. The proposal also incorporates formal training for the PI in clinical research and statistics through the Altman Clinical and Translational Research Institute. The overall objective of this proposal is for the PI to establish a foundation for an academic career studying clinically relevant heart-lung-sleep interactions, to which he is firmly committed.

Public health relevance
Project Narrative: Sleep apnea is common in patients admitted to the hospital with congestive heart failure. The goal of this research is to determine if the presence of sleep apnea contributes to heart stress or damage. Findings of this study may be important to guide further research aimed at improving care of patients with heart disease.